Somatic regulation of embryonic germline dynamics by isoprenoids

PROJECT SUMMARY/ABSTRACT
The development and protection of the germline is critical to the fertility and the health of the next generation.
My long-term objective is to elucidate the mechanisms, regulation and coordination of embryonic germline
processes as an independent investigator. Emerging evidence suggests that the secreted isoprene lipids,
retinoic acids and juvenile hormones, have more than one role in the germline lifecycle in vertebrate and
invertebrate animals, respectively. Juvenile hormone signaling has been implicated in several aspects adult
gametogenesis while retinoic acid has a prominent role in the regulation of meiotic onset timing. However, no
shared function for these two isoprenoids have been found to-date despite a high degree of structural
similarity, cross-activation capacity, and shared expression patterns during embryonic germline development.
Based on a wealth of preliminary studies, the central hypothesis guiding this proposal is that juvenile hormone
impacts embryonic germ cell dynamics through a non-classical mechanism and that two functions of retinoic
acid and juvenile function in embryonic germ processes are conserved between insects and mammals. Three
aims will be completed to test this hypothesis. First, the impact of juvenile hormone will be determined with two
approaches. Spatiotemporal juvenile hormone titers will be measured spectrometry-based metabolomics to
elucidate the source of juvenile hormone. Then, the impact of juvenile hormone on germ cell dynamics will be
determined using live imaging analysis in Drosophila melanogaster embryos. Second, the non-classical,
transcription-independent, mechanism of juvenile hormone function will be elucidated by proteomic
identification of the juvenile hormone-binding plasma membrane receptors coupled to functional verification,
Downstream signaling events will be elucidated using live imaging microscopy in D. melanogaster embryos.
Third, the conservation of isoprene lipids on the embryonic germline will be defined by elucidating the impact of
retinoic acids on germ cell dynamics in Mus musculus embryos by ex vivo and in vitro necessity and
sufficiency assays. Concomitantly, conservation of the post-migratory role for isoprenoids will be examined by
defining the role of sex-specific differences in juvenile hormone titers in D. melanogaster germline
development. Upon successful completion of this work, the impact, mechanism and conservation of juvenile
hormone and retinoic acid on the embryonic germline will be defined. These insights will be important as these
bioactive isoprenoids are pervasive in our environment. In fact, juvenile hormone analogues are the active
ingredient of many insecticides used throughout the world and have been shown to activate retinoic acid
signaling in mammalian cells. Thus, understanding the full impact of these isoprenoids on the embryonic
germline is critical and the efforts to gain such understanding align well the general mission of the Eunice
Kennedy Shriver National Institute of Child Health and Human Development to ensure every person is born
healthy, productive, are free of disease.

Public health relevance
PROJECT NARRATIVE Development and protection of the germ cells are required for human fertility. In this proposal, I aim to understand the role of the small, bioactive isoprene lipids, juvenile hormone and retinoic acids, in embryonic germline development. As both isoprene lipids are common in our environment, understanding their full impact in germline development is critical.